Standardizing Portion Sizes

Abstract This application is for a planning grant to develop an RCT to test the impact of standardized portions in away-from home settings. Given that restaurants all serve different portions and generally serve more food than most customers can burn, making portions standardized and predictable could help millions of Americans control how much they eat and reduce their risk for overweight and obesity. We plan to establish what standard portion sizes should be for different items; develop practical methods by which restaurants could adopt these standard portions, and develop and test recruitment methods and measurement of participants. The establishment of standardized portion sizes will serve as an aspirational benchmark for the food industry to comply with recommendations from the USDHHS/USDA Dietary Guidelines of Americans) and will provide guidance for consumers. An implementation plan, informed by restaurateurs and consumers, is necessary for a rigorous RCT, which would need to enroll many restaurants and their customers. In this planning grant our specific aims are: 1) Develop a consensus among health and nutrition experts as to what the standardized portion amounts should be and how they should be measured (e.g. weights, volumes, and relevance of calories). 2) Pilot test and refine a training in three varied restaurants [Locando Del Lago (Italian), El Cholo (Mexican) and Li’l Dizzy’s (Creole)] to examine feasibility and adherence to the recommended standards. 3) Pilot recruitment methods for customers, assess response rates and perceptions of standardized portions, and pilot 24-hour dietary recall methods. Once these aims have been accomplished, we will be able to prepare for a rigorous RCT to determine the impact of standardized portions sizes on diet, and specifically on how standard portions will influence the consumption of nutrients of consequence to cardiovascular health, especially reducing exposure to refined grains, starches, sugars, processed meats, high sodium foods, and increasing consumption of fruits, vegetables, fish, vegetable oils, nuts, low-fat dairy, and whole grains.

Public health relevance
Narrative Given that restaurants all serve different portions and generally serve more food than most customers can burn, making portions standardized and predictable could help millions of Americans control how much they eat and reduce their risk for overweight and obesity. This planning grant for an RCT to test the impact of standardized portion sizes in away-from-home settings will establish what standard portion sizes should be; develop practical methods by which restaurants could adopt these standard portions, and develop and test methods for recruitment and measurement of participants.